Perceptual decision making over the lifespan

Project Summary
Visual perceptual decision-making (PDM) is a ubiquitous process that translates our noisy visual experience of
the environment into associated perceptual decisions. PDM is important as it directly influences how we
interact with our surroundings and form our behavior. From prior studies, we know that many cognitive
processes undergo a developmental change as we age, usually characterized by an inverted U-shape pattern:
increasing function from childhood to early adulthood and a later decline in senescence. However, there is no
direct evidence about the full lifespan trajectory of PDM. We identified three gaps in our understanding of PDM:
1) PDM in children is not well studied, likely because of methodological issues, 2) conclusions about lifespan
PDM trajectory are only derived by indirect comparisons between separate studies, and 3) we do not have a
clear understanding about how noise interacts with PDM ability in children and older adults; this is notable as
PDM often becomes a key limiting factor in behavior under conditions of high stimulus noise. The overall goal
of this proposal is to address these gaps in the literature by scrutinizing age-related effects of PDM as well as
using different methods to map out the typical development of PDM across the lifespan. In Aim 1, we propose
to examine PDM across the lifespan using two tasks (i.e., a random dot motion task and a categorization task).
We will use the classical reaction times (RT) method with modeling (i.e., DDM: drift-diffusion model), allowing
us to decompose RT into its components (i.e., evidence accumulation, non-decision time, and the decision
time) to illuminate age-related effects of the different components of PDM. Aim 1 is the first step to
understanding age-related effects of PDM and an important step to mapping out the typical development of
PDM. In Aim 2, we will explore the use of a complementary method, duration threshold which is characterized
by the shortest amount of time that is sufficient for individuals to perceive a stimulus, as a novel approach for
estimating temporal limits of PDM using the same tasks as Aim 1. This is a method with a clear benefit of not
necessitating complex modeling and it is more suitable for children and older adults as it eliminates non-
decision components (i.e., motor response). In Aim 3 we will use both classical (RT/DDM) and novel (duration
threshold) methods to examine how stimulus noise impacts PDM by including different levels of noise to the
tasks mentioned in Aim 1. Our sensory experience is inherently noisy and there is evidence that children and
older adults are more susceptible to stimulus noise. Our hypothesis is that the presence of noise will
exacerbate age-related deficits in PDM. This would be a significant advance in our understanding of PDM
lifespan trajectory as effective PDM can be particularly important under noisy sensory conditions (e.g., riding a
bike under low visibility conditions). In summary, the proposed research will provide novel insights about the
typical development and decline of PDM and, by extension, establish a baseline for studying atypical
development and aging in PDM (e.g., Autism Spectrum Disorder, Alzheimer’s Disease).

Public health relevance
Project Narrative Perceptual decision making (PDM), akin to other cognitive processes, undergoes developmental changes from childhood to senescence. The proposed project will investigate PDM using both classical (reaction times and sequential sampling model) and novel methods (duration thresholds) to characterize and discern the similarities and differences of PDM across the different stages of life and under different levels of perceptual noise. In addition, this will establish a baseline for conditions associated with atypical development and aging of PDM (e.g., Autism Spectrum Disorder, Alzheimer’s Disease).